Community Engagement Core

PROJECT SUMMARY (Community Engagement Core: Hoover, Chief, Carroll, Lim)
The University of Arizona (UA) Superfund Research Center (SRP) has successfully translated research
findings focused on the health and environmental impacts of mining on communities and engaged affected
citizens to reduce and mitigate exposure through learning modules, outreach activities, workshops, capacity
building, and developing community engaged participatory research. The objective of the UA SRC Community
Engagement Core (CEC) is to foster impactful collaborations between Center investigators and community
partners in identifying and mitigating human exposures to dust (including metals and mold) from mine waste
and material. Recognizing that reducing chronic metal(loid) exposure remains a priority, congruent with NIEHS
SRP’s fourth mandate, we will establish and maintain space for multi-directional communication to 1)
Implement community engagement training activities that prepares UA SRC members to engage communities
in multi-directional dialogue; 2) Develop educational and informational materials that support efforts by
Indigenous Peoples to reduce environmental exposures in their communities; and 3) Enhance community based
capacity to reduce dust exposure via co-created data collection and monitoring activities. Accomplishing
these activities will be achieved through existing, long-term collaborations with The Tohono O’odham Nation,
The Navajo Nation, Diné College, San Carlos Apache College, and Black Mesa United community
organization. CEC activities will emphasize co-development of educational and information materials to build
community capacity to address and reduce environmental dust exposures. In collaboration with the Research
Experience and Training Coordination Core (RETCC), the CEC will 1) develop educational and informational
materials to support community decision-making about issues including particulate matter, mold, and lung
disease with support from Projects 1 and 2; 2) facilitate community training events for dust collection and
characterization (in collaboration with Project 3); 3) establish a working group to design and deploy a sensor
network for communities to collect their own dust data; and 4) lead discussions with community partners about
phytoremediation as a tool for reducing dust exposure, metals immobilization, and recovery (with support from
Project 4). The CEC intervention framework also includes collaboration with the Data Management and
Analysis Core to support community access to data and visualization tools, congruent with Indigenous Data
Sovereignty principles. Engagement with Indigenous Peoples will increase awareness of ways honor
Indigenous sovereignty and knowledge through research and foster university-community partnerships based
on trust and transparency.

Public health relevance
PROJECT NARRATIVE (Community Engagement Core: Hoover, Chief, Carroll, Lim) The University of Arizona (UA) DUST Superfund Research Center (SRC) Community Engagement Core (CEC) seeks to engage communities confronting environmental health threats from legacy and active hardrock mining sites using an engagement framework that centers Indigenous values and principles. Planned activities to support community-engaged research are oriented around three crosscutting themes of training; educational and informational materials; and community capacity building. The tools co-developed by the UA SRP CEC team and community partners will be used for multi-directional communications and support efforts to improve community health and well-being by reducing dust and metal exposures from mine sites.